Dynamics of the Neuronal Cytoskeleton in Aging Brain

DESCRIPTION (provided by applicant): Neurofilaments (NF) enable axons to achieve the large calibers required for normal nerve impulse conduction and play other critical roles in neuronal function only now being appreciated. In several major neurodegenerative diseases, including a form of fronto-temporal dementia, abnormal accumulations of NF are a neuropathologic hallmark believed to contribute to neuronal dysfunction. Indeed, the association of NF gene mutations with Charcot Marie Tooth type 2E/1F neuronopathy and with early-onset Parkinson's disease (PD) unequivocally implicates NF directly in neurodegenerative disease pathogenesis. Our studies in the past grant term revealed new fundamental properties of NF and suggested a novel function for NF as a scaffold in axons and synapses, which reversibly docks vesicular organelles and proteins, including neurotransmitter receptors, and thereby may regulate their function. We identified the middle subunit of NF (NFM) as uniquely crucial for NF transport and key NF scaffold functions. We propose to test hypotheses, based on preliminary data, that the head and rod domains of NFM regulate NF transport and trigger NF network formation along axons. By replacing endogenous NFM in neurons with genetically modified and truncated forms of NFM, we propose to define roles of the head and rod domains, including head phosphorylation, and the effects on NF behavior of a NFM mutation associated with severe PD (aims 1a-d). Studies will be performed in primary neuronal cultures using videomicroscopy and in retinal ganglion cells in vivo by established radiolabeling and ultrastructural methods, exploiting the previously successful approach we used to define functions of NF carboxyl- tail domains. Having pinpointed NFM rod as the likely binding site for NF motors, we will perform genetic screens to identify putative NF motor(s) (aim 1e). Based on new findings that NFM and the D1 dopamine receptor (D1R) interact functionally to modulate D1R -mediated behaviors in vivo, we will test the hypothesis that D1R docking to a NFM-containing scaffold influences endocytic recycling of D1R to synaptic membranes and thus sensitivity to DA agonists (aim 2). We will characterize D1R recycling in striatal primary neurons of mice with NFM deletion or related alterations and will ultrastructurally and biochemically localize D1R-NFM interaction sites within neurons in vivo. Finally, we will clarify the poorly understood role of proteolysis in regulating NF accumulation and NF network stability and its modulation by NF structural properties as a basis for understanding pathological NF accumulation in neurological diseases and brain aging (aim 3). Novel approaches to alter the in vivo activities of three major proteolytic systems implicated by our preliminary data and protease modulations in primary neurons will be used. These studies address fundamental aspects of NF biology related to the normal functions of axons and synapses and are directly relevant to mechanisms of neuroaxonal degeneration in neurofibrillary diseases, including Alzheimer's disease and related dementias, amyotrophic lateral sclerosis and related neuronopathies, Parkinson's disease and glaucoma.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project addresses how neurons assemble an internal supporting framework enabling them to connect and communicate with other neurons. The regulation of this process controls important neuron functions and is known to be disrupted in neurodegenerative diseases associated with aging. Defining the specific steps in this regulation will help to clarify mechanisms leading to major neurological diseases, including dementias, and will identify novel cellular targets for developing innovative therapies for these diseases. This project addresses how neurons assemble an internal supporting framework enabling them to connect and communicate with other neurons. The regulation of this process controls important neuron functions and is known to be disrupted in neurodegenerative diseases associated with aging. Defining the specific steps in this regulation will help to clarify mechanisms leading to major neurological diseases, including dementias, and will identify novel cellular targets for developing innovative therapies for these diseases. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS In achieving the objectives of our preceding term of support, we gained new insights into the fundamental structure and dynamic behavior of neurofilaments (NF) and into novel physiological roles of NF and their individual subunits, which form the basis for this renewal application. We identified a singular importance of the middle molecular weight NF subunit (NFM) as being a "master subunit"- uniquely essential for axonal transport of NF in vivo and for regulating their transport rates, among other key roles. Our preliminary data attach particular importance to the NFM head and rod domains in NF transport functions. We established a novel role for NFM subunits in regulating neurotransmitter receptors in vivo and we implicated NFM in forming the stationary NF network along axons, which is essential for axon caliber expansion during brain maturation. A major theme in this renewal application is the further definition of these important physiological functions, how the specific domains of NFM and their ligands mediate these functions, and how NFM alterations may contribute to neuropsychiatric disorders. Reconciling previous controversial in vivo and in vitro data, we have demonstrated unequivocally that NF in mature axons form a large stationary cytoskeletal network that intercalates with other fibrous cytoskeletal elements and is maintained by smaller pools of transported NF and possibly subunit oligomers. Beyond its critical role in axon caliber expansion, this NF network, as our data indicate, plays a novel role in organizing proteins and vesicular organelles in axons and synapses, involving the molecular motor Myosin Va (Myo Va) as a key factor. As a second major theme of our application, we propose to define further the scaffold functions of the NF network, including determinants of scaffold formation, stability and regulation. Related to these scaffolding roles, we showed that direct interactions of the NFM subunit with the dopamine D1 receptor (D1R) influence its activity in vivo. We propose to extend these exciting findings and define the mechanism underlying NFM regulation of D1 receptor activity. Finally, we revealed a remarkable resistance of the NF network in axons to proteolysis, which leads us to propose that NF turnover regulation is a particularly crucial determinant of whether NF accumulate locally in neurons in health and neurodegenerative states. Surprisingly, little is known about the mechanisms that regulate protein turnover of NF subunits, the influences of assembly state and post-translational modifications on NF proteins, and the relevance of NF turnover to disease and aging. Our promising preliminary data, implicating multiple proteolytic systems affecting NF subunit turnover and major influences of NF structure on NF turnover, underscore the likely importance of this fundamental and understudied process to NF biology and pathophysiology. Aim 1: The importance of head and rod domains of NFM as regulatory sites for key NFM and NF functions will be determined using approaches successfully used in our previous studies of C-terminal NF tail domain function. Aim 1a. Test the hypothesis that the NFM head domain regulates NF axonal transport kinetics: Effects of deleting the NFM head domain (NFM head ) on NF subunit transport kinetics will be determined in primary cortical neuronal cultures using an EGFP-tagged NFMhead expression construct compared to full length and tailless (tail ) constructs of NFM and in NFMhead knock-in mice, constructed by our established methods1*. Aim 1b. Test the hypothesis that the NFM head domain is essential to initiate formation and stabilization of stationary NF network in axons: The same constructs in Aim 1a will be applied in primary neurons using established photobleaching techniques and ultrastructural analyses and in NFM head knock-in mice using previously validated methods. Aim 1c. Test the hypothesis that phosphorylation regulates the specific functions of the NFM head domain described in Aims 1a and 1b. Effects on function will be assessed after mutating 4 known phosphorylation sites on the NFM head domain to mimic either permanent phosphorylation (Ser to Asp) or dephosphorylation (Ser to Ala). Aim 1d. Determine the effects of the NFM rod domain mutation (Gly336Ser) linked to early onset severe Parkinson's disease (PD) on NF functions in Aim 1 and Aim 2. Aim 1e. Identify NFM-interacting motors for slow NF transport: Our data strongly suggest that the head or rod domain of NFM contains the binding site(s) for NF transport motor(s). Yeast two hybrid screen with NFM head and rod constructs will be used with shRNA silencing analyses in our in vitro transport paradigms to identify and validate putative NF motors that bind NFM. Aim 2. Define how NFM-D1R interactions influence D1R distribution and function. Aim 2a: Test the hypothesis that NFM regulates D1R functions by modulating receptor endocytic recycling. Based on our preliminary data supporting a relationship, we will determine effects of deleting NFM versus other NF subunits on D1R endocytosis and recycling in primary striatal neurons. Aim 2b: Determine how NFM modulates the subcellular distribution and ultrastructural localization of D1R in vivo. Immunogold electron microscopy, subcellular fractionation, and co-immunoprecipitation analyses will be used in mouse NF models to confirm and extend preliminary data that NFM is present in synapses and associates with D1R in a pattern consistent with a role in D1R recycling. Aim 3: Identify the proteolytic systems responsible for turnover of NF proteins and mechanisms that confer extreme proteolytic resistance to NF in axons: Aim 3a: Define the roles of the calpain, proteasome and autophagy pathways in NF proteolysis and the influence of NF structural properties and assembly state as determinants of the extreme resistance NF to proteolysis in neurons. Under conditions in which the 3 major proteolytic systems normally assembled NF are selectively modulated, we will measure proteolysis of WT NF subunits in assembled NF, in neurons from mice lacking NFH/NFM C-terminal domains and in NF gene-deleted mice, which model developmentally immature NF or a state in which filament assembly is largely inhibited but oligomeric subunit transport is preserved. Aim 3b: Implicate specific proteolytic systems in NF turnover in brain in vivo. Mouse models including novel conditional Atg7 KO to modify autophagy, calpastatin (CAST) transgenic overexpression to inhibit calpains, and proteasome inhibitor infusions will be used to modulate proteolytic activities in vivo and to assess effects on NF turnover, NF levels, and NF function in mice expressing C-terminally truncated NFM and NFH that increases proteolytic susceptibility of NF subunits, which enables us to monitor and measure NF turnover.